Genomics of OCD in Latin American Communities

Project Summary/Abstract
In this study I seek to understand how common and rare genetic variation influence the risk of developing
obsessive-compulsive disorder (OCD). OCD is a disabling psychiatric disorder with as yet unclear underlying
pathophysiology, which has hindered the development of new treatments and interventions. While there is a
clear genetic contribution to OCD risk, decades of investigations have yet to yield reproducible, statistically
significant findings that identify high-confidence risk genes. In other neurodevelopmental psychiatric disorders
(NDDs), including schizophrenia, attention-deficit/hyperactivity disorder and autism, genome-wide association
studies (GWAS) and whole exome sequencing (WES) in large numbers of subjects are now identifying risk genes
and loci, paving the way for novel therapeutics. Increasing sample sizes in OCD, and applying multi-omic
approaches, will lead to similar advances in OCD. Of note, in spite of the advances in NDDs, studies to date
were primarily carried out in samples of European Ancestry (EA), so we know comparatively less about the
genetic architecture of these disorders in non-EA populations. To address these gaps, with the ultimate goal of
studying the role of common and rare deleterious variation in OCD risk, I will work on emerging, large-scale WES
studies in OCD, collaborate in ongoing common variant studies, and collect and analyze Latinx OCD samples.
To achieve these goals, during the K99 phase, I will first be trained on, and make use of, relevant statistical
genetic methods using suitably powered samples of autism and other psychiatric disorders, while building a
Latinx OCD cohort. The R00 phase will focus on meta-analyses of OCD genetic data, including the Latinx cohort,
using well-established pipelines. This will increase power to identify OCD risk genes and loci, and will enable
functional approaches using gene findings to study pathways, cell-types and developmental stages implicated
in OCD risk. Furthermore, since studies of cross-disorder risk are an opportunity to enhance gene discovery by
combining datasets, in the R00 phase shared risk between psychiatric disorders will be leveraged in exploratory
analyses in the OCD gene and locus discovery efforts. Ultimately, I plan to obtain a tenure-track faculty position
and launch a laboratory that focuses on the integration of genetics and neurobiological approaches, to discover
mechanisms underlying NDDs. These efforts will begin with OCD, using genome-wide techniques and leveraging
admixed and diverse populations, and expand into other NDDs. I will also use the K99 phase to deepen
knowledge in writing manuscripts and grants, and to improve skills in presenting complex studies to both mixed
and specialty audiences.

Public health relevance
Project Narrative Obsessive-compulsive disorder (OCD) is a debilitating psychiatric disorder, yet its etiology is largely unknown and treatment could be improved, and perhaps even personalized, if biological targets could be identified. Our goal in this study is to learn more about what precise genetic factors influence risk for OCD. We propose to do this by investigating both common and rare genetic variants in a large OCD cohort including samples of admixed and diverse ancestrally.